Cellular and Molecular Biology at Michigan

Project Summary
This application requests support for the new and redesigned Cellular and Molecular Biology Ph.D. Program
(CMB) at the University of Michigan (UM). The mission of the CMB program is to train a diverse group of scientists
to conduct responsible and rigorous research in cellular and molecular biology and to prepare them to be
successful in diverse careers in biomedical sciences. To pursue this mission, CMB will use evidence-based
methods to train students in discipline-related and transferable skills via an individualized and structured
competency-based curriculum, train faculty in effective mentoring practices, and use systematic evaluation and
intervention to continuously improve its inclusive training practices. Discipline-related training includes
foundational coursework and seminars in cell biology, biochemistry, genetics, and quantitative biology, broad
exposure to research via weekly Student Seminars, student-organized Short Courses, an Annual Research
Symposium, and an Annual Retreat, deep knowledge of an area via rigorous and reproducible research in
mentored dissertation projects, and experiential learning in a wide range of areas in basic and translational
biomedical sciences. Training in transferable skills range from competency-based courses (such as on scientific
communication) to experiential workshops (such as on leadership) offered at the programmatic and institutional
levels. Key new elements include 1) competency mapping to courses with a renewed focus on transferable skills
and professional development, 2) structured requirements for training in “Rigor and Reproducibility”,
“Responsible Conduct of Research”, and scientific communication, 3) a Guided Actionable Plan for career
development, 4) the addition of mentor training for faculty and an individualized mentoring plan for each student
as requirements, 5) intentional diversity, equity, and inclusion (DEI) efforts, and 6) the addition of formative
evaluation strategies for programming. CMB has strong institutional support from the UM Medical School and
from Rackham Graduate School, as well as from individual departments that participate in the program. Faculty
in the program are scientifically diverse and well-funded, and the program actively and successfully recruits an
outstanding and diverse group of students from a national pool. Approximately 75% students join via the umbrella
Program in Biomedical Sciences (PIBS, covering 13 biomedical Ph.D. programs) and 25% from the Medical
Scientist Training Program (MSTP). In this application, we request annual support for 16 trainees, as 8 2nd year
students and 8 3rd year students. Modern biomedical science has become increasingly collaborative and team-
based, and there is a clear need for researchers with an operational knowledge of a wide range of disciplines
while holding deep expertise of their focused discipline. As a long-standing interdisciplinary collaboration
between 20 departments across 4 colleges, CMB is uniquely positioned to fill this need by training new
generations of scientists to collaboratively and address fundamental questions in cellular and molecular biology
and generate innovative research strategies bridging basic and translational fields to improve human health.

Public health relevance
Project Narrative: The research performed by students in the CMB program addresses fundamental questions about the nation’s pressing public health concerns, including prevalent chronic disorders (e.g., cancer, diabetes, heart disease), neurological conditions (e.g., Alzheimer’s, epilepsy, addiction), and infectious diseases (e.g., COVID, MRSA). Training a diverse pool of students, using evidence-based approaches that combine broad exposure and focused training of students in cellular and molecular approaches, effective mentor training, and program evaluation at multiple levels, fills a critical need for producing well-trained scientists in the biomedical workforce who work to advance fundamental knowledge in areas relevant to advancing health, reducing illness and improving the quality of human life.